Functional and Mechanistic Characterization of Lupus Susceptibility

PROJECT ABSTRACT
Systemic lupus erythematosus (SLE) is a complex autoimmune disease characterized by chronic inflammation
and multi-organ involvement, leading to significant morbidity and mortality. SLE disproportionately affects women
and individuals of Asian, African, and Hispanic descent, with a higher prevalence and severity compared to other
populations. Despite advancements in research, the molecular mechanisms underlying SLE remain poorly
understood, and current therapies are often insufficient due to clinical heterogeneity and unpredictable disease
trajectories, underscoring the urgent need for novel interventions.
Autophagy, a critical cellular mechanism for maintaining homeostasis, has emerged as a key player in SLE
pathogenesis. Dysfunctional autophagy disrupts cellular processes, including lysosomal function, antigen
presentation, and cytokine regulation, which are central to both immune and non-immune cell functions. While
B and T cells have long been implicated in SLE, recent evidence highlights the role of classical monocytes
(CD14++CD16−) and kidney-resident podocytes in driving disease progression. In SLE, monocytes exhibit
impaired autophagy, resulting in defective phagocytosis and heightened production of pro-inflammatory
cytokines, such as TNF-α and IL-6, fueling systemic inflammation. Similarly, podocytes rely on autophagy for
maintaining structural integrity and glomerular filtration. Autophagy impairments in podocytes lead to cytoskeletal
damage, apoptosis, and proteinuria, which are hallmark features of lupus nephritis.
Genome-wide association studies (GWAS) have identified numerous SLE susceptibility loci; yet translating
these findings into mechanistic insights remains challenging. Our study focuses on four key GWAS loci linked to
genes involved in autophagy, lysosomal function, and apoptosis—pathways crucial for immune regulation and
tissue homeostasis. We hypothesize that genetic variants within regulatory elements of these genes disrupt
autophagy, exacerbating immune dysregulation and organ-specific damage in SLE.
Aim 1 involves fine-mapping SLE susceptibility loci through imputation-based analysis of resequencing
data from patients and controls. Functional variants will be prioritized using allele-specific expression, chromatin
profiling, and 3D genome interaction data, followed by genotyping validation.
Aim 2 evaluates the functional impact of these variants on autophagy and cellular processes using
CRISPR-based modifications in immune (e.g., THP-1 monocytes) and non-immune (e.g., podocyte) cell models.
Complementary studies in primary monocytes from SLE patients and healthy controls will validate findings. By
elucidating the role of autophagy-related genetic variants in SLE, this research aims to uncover novel
mechanisms of disease and identify therapeutic targets for precision medicine approaches.

Public health relevance
PROJECT NARRATIVE Lupus, a chronic autoimmune disease, disproportionately affects women and specific ethnicities, specifically Asians, resulting in significant morbidity and mortality. Genetic studies have associated single nucleotide polymorphisms (SNPs) in genes regulating autophagy, apoptosis, lysosomal function, and inflammasome activation with an increased risk of lupus. This project aims to identify lupus-predisposing variants within four well-established SLE loci linked to Asian populations and elucidate their functional roles in immune and non- immune cells to uncover the molecular mechanisms driving SLE pathogenesis across diverse populations.